Chemical Approaches to Control the Function of Regulatory RNAs

Recent decades have dramatically changed our view of RNA. While RNA was initially believed to be barely
a passive messenger in the transfer of genetic information from DNA to proteins, it is now clear that RNA is
an exciting and underexplored regulatory molecule that will continue to deliver new discoveries new
discoveries in biology and medicine. Our research is focused on using chemical modifications to modulate
the structure and function regulatory RNAs. The long-term goals are to 1) develop novel RNA chemical
modifications for fundamental studies and biomedical applications, and 2) explore new modes of sequence-
specific recognition of double-stranded RNA (dsRNA). Our research program comprises two distinct but
interrelated projects: 1) amides as novel backbone modifications for regulatory RNAs, and 2) sequence-
specific recognition of dsRNA by modified peptide nucleic acids (PNA). Project 1 replaces internucleotide
phosphates with amide linkages in short interfering RNAs and RNAs associated with clustered regularly
interspaced short palindromic repeats (CRISPR). The goals are to improve the cellular uptake, delivery and
sequence specificity of these RNAs. The premise is that amides can mimic structure and H-bonding
interactions of phosphates with proteins and, at certain positions, may be able to remodel and improve
these interactions. Project 2 explores chemically modified PNA as a ligand for sequence-specific
recognition of biomedically important dsRNA. The goals are to improve the cellular uptake of PNA and to
demonstrate the biological effect of triplex formation using microRNAs as the initial model system. The
premise is that M-modified triplex-forming PNAs are uniquely suited for sequence-specific recognition of
dsRNA and will enable recognition of biologically important non-coding dsRNA. Future research will focus
on chemical modifications of CRISPR RNAs and using the triple helix to control conformations of complex
non-coding RNAs. The two projects share a common theme of designing chemical modifications that take
advantage of charge complementarity between the RNA target and the ligands and proteins interacting with
RNA. The overreaching idea is to develop RNA chemical modifications and RNA binding ligands that avoid
unproductive electrostatic repulsion and capitalize on productive electrostatic attraction while concurrently
enhancing sequence specificity of molecular interactions. This thrust grows out of our recent discoveries
that RNA is unusually receptive to chemical modifications that neutralize the negative charge of phosphate
backbone, both in RNA itself and in RNA binding oligonucleotide analogues. If successful, our research will
contribute to addressing key gaps in RNA interference, CRISPR, recognition of therapeutically relevant
RNAs, and will open doors for development of unique research tools and new therapeutic strategies.

Public health relevance
Double-stranded RNAs are exciting regulatory molecules, powerful tools for basic biological sciences and hold great promise to become novel therapeutics. This proposal will explore chemical modifications to optimize the properties of such RNA molecules and study the mechanism of their action. If successful, the project will create improved research tools, provide unique insights into structure and function of RNA and may open the doors for development of new drugs for diseases where the traditional pharmaceutics have been less successful.